Elucidating Effects of Fibrosis on Aged Stem Cells with Dynamic Biomaterials

PROJECT SUMMARY
Despite the ubiquitous role of fibrosis in tissue dysfunction arising from aging and disease, no
representative in vitro model of the fibrotic microenvironment exists. Fibrosis is characterized by excess
extracellular matrix (ECM) deposition that stiffens the cellular microenvironment. Therefore, to model fibrosis in
vitro, cell culture substrates that permit quantitative, dynamic tuning of matrix mechanics and composition are
necessary. However, existing dynamic hydrogel culture platforms generally rely on chemistries that may be
toxic to cells or that simultaneously change multiple parameters, making it difficult to assign causal
relationships between altered matrix properties and cell fate changes. Fibrotic stiffening occurs in a wide range
of tissues, including skeletal muscle. Along with increased fibrosis, the regenerative function of skeletal muscle
decreases with aging. Muscle stem cells (MuSCs) are responsible for maintaining and repairing muscle
throughout life and are known to be acutely mechanosensitive, losing their stem cell potential when cultured on
stiff substrates. Thus, the stiffened, fibrotic microenvironment may contribute to the diminished regenerative
capacity of aged MuSCs. The goal of this project is to develop an in vitro model of tissue fibrosis based on
dynamic hydrogel biomaterials and to employ this model to identify molecular mechanisms of MuSC
mechanosensing that are implicated in MuSC dysfunction in aging. The mentored phase of this proposal will
provide advanced technical training in aging biology, transgenic mouse models, cellular traction force
measurement, and machine learning approaches for bioinformatics. This training will enable an independent
research program leveraging dynamic biomaterials to deconvolve the complex interactions of mechanical
forces, matrix biochemistry, and cell-cell signaling that dictate the progression of aging and disease. Additional
structured training in scientific writing, grantsmanship, and research management will facilitate the transition to
independence, supported by a committee of faculty from the Stanford Schools of Medicine and Engineering.
Aim 1 will optimize a synthetic hydrogel system that uses near-infrared light and bioorthogonal reactions to
dynamically stiffen the gels, mimicking fibrosis. These hydrogels will be used to elucidate mechanisms of
mechanosensing in MuSCs, using FRET-based force sensors and transgenic mouse models. Aim 2 will model
muscle aging in vitro, using dynamically stiffening gels modified with ECM components characteristic of aging.
Single cell RNA sequencing and machine learning bioinformatics approaches will identify unique mechanically
regulated drivers of cell fate that reduce MuSC regenerative potential in aging. Aim 3 will develop novel
materials for 3D cell culture with dynamic tuning of viscoelastic properties to establish the first human model of
muscle “aging in a dish.” This project stands to identify new therapeutic targets to improve muscle function with
aging and to develop engineered platforms to study numerous heritable diseases and aging in diverse tissues.

Public health relevance
PROJECT NARRATIVE Fibrosis, which causes dysfunction and ultimate failure of numerous tissues with aging, is characterized in part by increased tissue stiffness. Despite the profound impact of fibrosis on the health of our aging population, no adequate model system exists to study fibrotic stiffening on individual cells in real-time. This project aims to develop a dynamic material platform that enables user-directed manipulation of stiffness and to apply this system to identify aging-related changes in muscle stem cells that could lead to novel therapies to improve muscle function in aged individuals.